Social Connectedness and Health among Gender Minority People of Color

PROJECT SUMMARY
Gender minority people of color (GM POC) have documented disparities in mental and physical health. These
disparities have been attributed, at least in part, to minority stress. Perceived social support has been shown to
be protective, and may buffer the impact of minority stress on health. However, little is known about the social
relations and connectedness of GM POC. This study therefore examines the social relations of GM POC and
identifies targets for future interventions to enhance their social connectedness, health and wellbeing. Guided
by the Convoy Model of Social Relations, the study aims to: (1) Examine the social relations and connectedness
of GM POC age 18-69 through in-depth, qualitative interviews (N = 60); (2) adapt the established structured
Social Convoy Interview protocol to quantitatively assess the contemporary social networks and support of GM
POC adults through a series of cognitive interviews (N = 24); and (3) identify strengths and weaknesses in social
connectedness that moderate the association between minority stress and outcomes of mental health and aging
among a community sample of GM POC (N = 360). GM POC will be recruited through venue-based sampling in
the New York City and New Orleans metropolitan areas, two cities that differ in structural stigma, both in terms
of policies related to gender diversity and history of systematic racism. The study will combine self-report
interview data and telomere length as a biomarker of aging. The study will result in an in-depth understanding of
the social connectedness of GM POC; an instrument to assess the contemporary social networks of this minority
population; and generalizable knowledge about the mechanism of how social support may buffer the negative
impact of minority stress on health. Findings will inform future interventions to reduce social isolation and
disparities in health among gender and racial/ethnic minority populations.

Public health relevance
PROJECT NARRATIVE Gender minority people of color face disparities in health and wellbeing, which have been attributed (at least in part) to the negative impact of minority stress on health, while perceived social support has been shown to be protective. This study will examine the social support networks of gender minority people of color both qualitatively and quantitatively, and identify strengths and weaknesses in social connectedness that moderate the relationship between minority stress, health and wellbeing. Findings will inform the future development of interventions to reduce social isolation, promote resilience, and improve health and healthy aging.